Continued development of a risk-based Animal Feed Inspection Program within the NCDA&CS through continuous implementation of uniform policies that ensure Feed Safety and promote Compliance with FSMA

Project Summary/Abstract
Project Title: Continued development of a risk-based Animal Feed Inspection Program within
the NCDA&CS through continuous implementation of uniform policies that ensure Feed Safety
and promote Compliance with FSMA
Project Description: This proposal outlines the NCAFP’ plan to enhance the current risk-based
Animal Feed Inspection Program to include industry and regulator outreach, education, and
technical assistance to industry and regulators; in addition to inspection, compliance and
enforcement components. This proposal will detail the collaborations and processes to
accomplish goals under the Base AFRPS Maintenance Track and the PC for Animal Food
funding option of this funding announcement (PAR -20 - 132).
Project Goals: To maintain implementation of AFRPS and coordinate with FDA to implement
best practices for animal food regulatory work. By achieving and maintaining implementation of
these program Standards, the NCAFP can better direct their regulatory activities toward
preventing animal food safety hazards, that can cause illness or injury to animals or humans, in
facilities that manufacture, process, pack, or hold animal food materials/supplies.
Project Objectives: The NCAFP will achieve and maintain implementation of the AFRPS,
which is recognized as a critical element to creating a national, fully integrated food safety
system. The NCAFP further commits to contribute to the continuous improvement of the AFRPS
through attendance at an annual face-to-face meeting, active participation in committees, and
other Initiative supporting the AFRPS. This includes the development strategies for achieving
and maintaining implementation of the AFRPS that can be replicated or leveraged across state
programs to promote national consistency. To aid in further development of an Integrated Food
Safety System, the NCAFP will work to provide a foundation for supporting advisory/regulatory
action based upon findings of regulatory activities conducted by State animal food regulatory
programs and commits to research and coordinate with FDA to identify and implement best
practices for State animal food regulatory work performed under the scope of 21 CFR Part 507
CGMP and PC regulations, as well as other related FSMA provisions, which may be
incorporated as elements for future versions of the Animal Feed Regulatory Program Standards.

Public health relevance
Project Narrative Access to a supply of safe animal foods and feed ingredients is one the most crucial elements for ensuring the world’s population a safe human food supply. Utilizing the Animal Food Regulatory Program Standards, the North Carolina Food & Drug Protection Division will further develop the capabilities of their Animal Feed Regulatory Program to conduct comprehensive animal food safety inspections. under the scope of 21 CFR Part 507. We will strive to improve the safety and security of the US animal food supply and improve the protection of both human and animal health through this commitment to implement an inspection and enforcement program in partnership with FDA and other state regulatory programs.